Deciphering Determinants of Somatic Evolution with Single-Cell Genealogy

Project Summary / Abstract
Somatic cells undergo continuous evolution with heritable modifications through genetic and epigenetic
changes, influencing cellular competition and selection. Depicted as a detailed branching lineage map, a
cellular genealogy provides an essential scaffold to understand the causes and consequences of the somatic
evolutionary dynamics. However, the impact of various somatic modifications on genealogical dynamics and
cell states remains unclear, due in part to our limited ability to track somatic modifications within genealogical
contexts. To address this limitation, I propose to develop a somatic mutation-resolved lineage tracing system
that reconstructs a single-cell genealogical tree coupled with joint detection of somatic mutations and
epigenetic alterations (Aim1). To demonstrate the biological significance of this system and to advance our
understanding of hematopoietic stem cell (HSC) somatic evolution, I will trace the acquisition histories of
somatic mutations on HSC genealogical architecture and chart the evolutionary trajectory of normal aging
hematopoiesis and the leukemic transformation (Aim2). To tackle the causality in somatic evolution, I will
develop a genealogy-resolved massively parallel single-cell CRISPR screen to survey the causative effects of
somatic modifications on the genealogical dynamics and cellular functions at a large scale (Aim3). This project
will advance the frontier of studying genomic evolution in somatic cells, by revealing how genomic
modifications impact cellular dynamics. It paves the way to decipher the driving forces that shape somatic
evolution in broad areas essential for human health, including aging hematopoiesis, cancer progression, etc.
This project is a critical step for my long-term goal to advance our ability to observe, understand, and control
cellular behaviors and cell fate choices. Through the K99 phase of this proposed career development plan, I
will further strengthen my expertise and knowledge in mouse modeling, functional genomics, and leukemia
biology, as well as professional skills such as leadership, and lab management which are essential for my
successful independent career. These training goals will be achieved through joint mentorship between Dr.
Jonathan Weissman and Dr. Vijay Sankaran labs together with my advisory committee in a highly enriched
cross-institutional environment (Boston Children’s Hospital, Whitehead Institute, Broad Institute). When
combining these new skills with my rigorous training in single-cell genomics, stem cell, and computational
biology, I will be better prepared to transition into a successful independent research career.

Public health relevance
Project Narrative Cells within the human body undergo continuous evolution, accruing heritable alterations as they proliferate and differentiate into diverse cell types over time, forming a complex cellular genealogy. However, the driving forces that shape the genealogical structure are unclear. I propose to develop new approaches to link the somatic alterations to the cellular genealogy and uncover the causal mechanisms that reshape the evolutionary trajectories, demonstrated in both normal aging and leukemic transformation.